Development of an AI-empowered device that utilizes multimodal data-visualization to aid in the diagnosis, and treatment, of OUD

Abstract
Assessing the effectiveness of opioid use disorder (OUD), where high relapse rates create
financial and social tolls, is a pressing clinical problem in need of better measurement tools.
The ability to identify cognitive changes should improve outcomes but current intake into
rehabilitation programs doesn’t typically include cognitive tests. Simple, quick, cost-effective,
and objective measures are needed. This is the problem this proposal seeks to address.
This proposal utilizes the experience of 8 different rehab clinics which serve 150 patients
weekly, and WAVi, a commercialized brain-assessment platform that combines EEG evoked
responses (ERP) with 5 other tests also sensitive to addiction (heart rate variability, physical
reaction times, MoCA, Trail Making, and Flanker). This user-friendly platform focuses on
minimizing testing times and cost while maximizing information.
For this fast-track application, we will have the following milestones:
- Collect more OUD data from different clinics to refine existing clustering algorithm
and increase sensitivities and specificities so that we have a robust archetype for OUD
vs healthy patients
- Collect follow-up OUD data and correlate follow-up scans with successful outcomes
of rehabilitation treatment and therefore identify those addicts whose cognitive state
requires modified treatment approaches, with the aim of decreasing relapse rates and
recidivism rates.
- Develop a scalable multimodal product, including EEG with ERP, for rehabilitation
facilities that is readily accessible to clinicians and create a dynamic data asset to help
longitudinally predict outcomes.

Public health relevance
Narrative This project will create a clinically accessible device to be used as an aid to diagnosis for opioid-use disorder (OUD): assisting clinicians to identify OUD, to make intervention choices, and to better determine the timing of release from rehabilitation.